Cytokine regulation of mucosal inflammation

PROJECT ABSTRACT
Uncontrolled inflammation in the gastrointestinal tract underlies the pathogenesis and progression of multiple
chronic human diseases including allergy, hypersensitivity, inflammatory bowel disease (IBD), and graft-
versus-host-disease (GVHD), and there is an urgent need to develop novel approaches to prevent, limit or
reverse gut inflammation. The fundamental focus of our proposed renewal for R01AI145989 is to build on
recent paradigm-shifting results from the first funding cycle defining that tissue resident lymphocytes
shape the protective versus pathologic outcomes of key cytokines in gastrointestinal inflammation.
Specifically, our prior studies detailed how group 3 innate lymphoid cells (ILC3s) drive immune tolerance and
during homeostasis and inflammation by sensing and regulating key cytokine networks. We determined that
ILC3s sense IL-23 to upregulate the immunoregulatory molecule, CTLA-4, which critically restrains gut
inflammation (Ahmed et al., Nature, 2024). Further, we find that these cellular interactions are dysregulated in
the inflamed intestine of individuals with IBD. These surprising data provoke the need to more broadly consider
CTLA-4 biology beyond conventional T cells and in the context of distinct cytokine signals or microbial
exposures. We generated new preliminary data to support this renewal application where we propose to
mechanistically advance this paradigm. This includes two specific aims, which will define how specific tissue-
resident innate and innate-like lymphocytes augment different types of immunity and inflammation in the
intestine. We expect that our mechanistic results will provoke new opportunities for preventative, therapeutic or
curative treatment strategies targeting chronic gut inflammation.

Public health relevance
PROJECT NARRATIVE Uncontrolled inflammation in the intestine underlies the pathogenesis and progression of multiple chronic human diseases including allergy, hypersensitivity, inflammatory bowel disease, and graft-versus-host-disease, which collectively affect over 60 million Americans and requires over $28 billion dollars in annual health care costs. The focus of this proposal is to define the role and regulation of key pathways that control the beneficial versus pathologic outcomes of inflammation-mediating cytokines in the intestine.